PFP- Pilot & Feasibility Program

PROJECT SUMMARY/ABSTRACT – Pilot and Feasibility Program
The purpose of the Pilot and Feasibility Program (PFP) of the Washington University Center for Diabetes
Translation Research (WU-CDTR) is to promote innovative and transformative research designed to eliminate
disparities in diabetes by investigators new to the field. The PFP focuses on T2-T4 translational research
defined as ‘translating interventions and approaches that have demonstrated efficacy into real-world healthcare
settings, communities, and diverse populations with an emphasis on reach, sustainability, and potential for
widespread implementation’. The PFP provides initial research support over limited time periods to eligible
investigators exploring the feasibility of ideas or concepts related to the WU-CDTR mission to be the nexus for
transdisciplinary team science in advancing the conduct of next generation diabetes translation research.
A priority of the PFP is to attract and retain early-stage investigators conducting diabetes translation
research, and to successfully support the development of all investigators who are members of the WU-CDTR.
Members of the WU-CDTR are affiliated through Washington University in St. Louis; the University of Missouri in
Columbia, MO; and the Council on Black Health at Drexel University. The PFP allows investigators to develop
preliminary data sufficient to provide the basis for subsequent applications for independent research support from
outside granting mechanisms. The successes of this program can be demonstrated in significant new external
funding, career advancement, and publications of PFP grant recipients.
The specific aims of the PFP are to continue to provide support for: (1) new investigators in T2 to T4
diabetes translation research without current or past independent NIH research support; (2) established
investigators with previous work in diabetes translation research who want to explore innovative new directions in
research; and (3) established investigators from other scientific or disciplinary areas without previous work in
diabetes who are entering into new T2 to T4 diabetes translation research that represents a clear departure from
their ongoing research interests.
Future directions for the PFP, based on our Center mission and careful evaluation of this progress, will
build on principles of mentorship and collaboration to assure continued success of the program.